Dissecting the molecular composition and function of contact between membrane-bound and membrane-less organelles

PROJECT SUMMARY
Membrane-bound organelles interpret the cellular environment and metabolic status to regulate cellular
homeostasis. Lysosomes, once viewed as static membrane-bound organelles responsible for the disposal and
recycling of cellular waste, have been increasingly appreciated as signaling hubs that can sense cellular status
and regulate cellular metabolism. RNA granules, such as stress granules and transport granules, are membrane-
less organelles that assemble through multivalent interactions between RNA and proteins. RNA granules have
been hypothesized to act as hubs for RNA metabolism since they concentrate factors involved in various RNA
processing pathways. Despite increasing evidence showing membrane-less organelles are essential parts of
cellular compartmentalization, how they coordinate with membrane-bound organelles to organize cytosolic
space and regulate cell homeostasis remains poorly understood. I have recently discovered a novel contact
between lysosomes and RNA granules, which has opened up new areas of research on interactions between
membrane-bound and membrane-less organelles. The overarching goal of this proposal is to understand how
membrane-bound and membrane-less organelles interact to maintain RNA homeostasis. We will use the
lysosome-RNA granule contact as a model, and employ multi-disciplinary approaches such as advanced light
and EM microscopy and proximity labeling-based omics, to investigate how the coordinated actions of
membrane-bound and membrane-less organelles ensure spatiotemporal control of RNA metabolism. In the first
project, we will use live cell imaging and volume EM to elucidate how lysosome-associated signaling, metabolites,
and lipid composition regulate RNA granule assembly and disassembly. In the second project, we will use
proximity labeling tools to dissect the RNA and protein composition of lysosome-RNA granules contact. In the
third project, we will use single-molecule tracking to explore the role of lysosomes in regulating mRNA localization,
translation, and degradation. The fundamental knowledge to be gained by this study will unveil the molecular
composition and function of contact between lysosome and RNA granule, and provide a framework for
understanding how membrane-bound organelle communicates with membrane-less organelle to maintain
cellular homeostasis.

Public health relevance
PROJECT NARRATIVE Membrane-bound organelle and membrane-less organelle both compartmentalize the cellular spaces. The proposed work seeks to understand how membrane-bound organelle lysosomes coordinate with membrane- less organelle RNA granules to regulate mRNA metabolism. Understanding the composition and function of the contact, and the complex interplay between membrane-bound and membrane-less organelles will pave the way for a better understanding of human health and diseases such as neurodegenerative disorders and cancer.